Therapeutic effects of APOE regulation via LNP-RNA formulations in Alzheimer's disease

PROJECT SUMMARY
Alzheimer's disease (AD) is a devastating neurodegenerative disorder affecting millions worldwide,
characterized by memory loss and cognitive decline. The Apolipoprotein E (ApoE) gene is closely linked to AD
risk, with APOE4 associated increased susceptibility while APOE2 exhibits protective effects, although the
mechanisms of this protection remain poorly understood. Nucleic acid-based therapeutics offer promising
avenues for treating AD by targeting pathological genes like APOE and promoting therapeutic protein expression.
However, their efficacy is hindered by challenges in crossing the blood-brain barrier (BBB). To address this, we
aim to develop novel lipid nanoparticles (LNPs) designed to interact with specific BBB-related receptors for
efficient delivery of nucleic acids to the brain. Our objectives include synthesizing novel BBB-crossing lipids (BLs),
formulating a library of LNPs, and elucidating their trafficking pathways across the BBB. Additionally, we will
engineer siRNA and mRNA sequences to modulate APOE4 and APOE2 expression, optimizing their design and
assessing their potency. Lastly, we will evaluate the therapeutic effects, pharmacokinetics, and safety of LNP-
RNA formulations in mouse AD models, including examination of brain delivery using PET/MRI imaging. This
comprehensive approach aims to advance our understanding of AD pathogenesis and develop innovative
therapies targeting APOE for the treatment of this debilitating disease.

Public health relevance
PROJECT NARRATIVE The development of effective treatments for Alzheimer's disease (AD) is crucial due to its debilitating effects on cognitive function and the increasing prevalence of the disease in the aging population worldwide. Apolipoprotein E (APOE) plays a critical role in the progression of AD. Novel lipid nanoparticle formulations for nucleic acids that modulate APOE may offer a promising avenue for therapeutic intervention and potentially attenuate the progression of Alzheimer's disease.